Molecular Basis of Host Parasite Interaction

The global burden of disease caused by microbial pathogens is one of the largest challenges facing the
biomedical community. Threats of emerging infectious disease and resistance to antimicrobial therapies highlight
the growing need for vaccines and therapeutics, plus training programs for scientists to ensure ongoing cuttingedge research will improve human health. The rationale for this Training Program, active for 35 years, is the
necessity for increased knowledge of the complex interactions between pathogens, microbiota, and the host
immune system. The multi-disciplinary Microbiology & Immunology department is a rich environment where
students learn to challenge established thinking and address scientific challenges. We aim to train the best and
brightest students and postdocs, with mentoring in the laboratories of Program faculty to gain the skills needed
to develop rigorous, impactful, well-funded research programs at the leading-edge of research in host-microbial
interactions. We provide a strong foundation in fundamental research elucidating the molecular mechanisms of
microbial pathogenesis and host-microbe interactions, while emphasizing translational research, human studies,
and the problems that clinicians face in the treatment of infectious disease. Additional key elements of the training
program include rigorous coursework, trainee-invited speakers, a departmental scientific conference for
presentation and interaction, and a student-organized scientific retreat for cohesion and scientific exchange.
Trainees are involved in teaching activities and are provided opportunities to become effective mentors and
teachers, including a required TA-ship. Program enhancements include added learning in critical concepts in
responsible conduct of research and increased emphasis on gaining knowledge in performing rigorous and
reproducible research through formal courses taught by Program faculty, and laboratory training. Graduate
student trainees are appointed upon admission to Stanford for up to 2 years; postdocs typically for 1 year; we
are requesting renewal of 6 graduate and 2 postdoctoral slots per year for 5 additional years of funding. Required
trainees-advisor IDP meetings along with substantial events and resources in career development facilitate
transitions into the biomedical workforce; for the past 10 years we have exceeded our goal of 95% retention of
our trainees in STEM-related fields. The Program benefits from the exceptional environment and we leverage
substantial School of Medicine and University resources, programs, and engagement. Students and postdocs
are successful, publishing high-impact papers and finding leading positions in all aspects of science, from
research to teaching to consulting to policy. Over our history, we have trained many who are now leaders in
biomedical research and we hope to continue this important and highly successful Training Program

Public health relevance
PROJECT NARRATIVE Investigations of host-microbe interaction, pathogenesis, and host immune responses are critical topics for inquiry in science and medicine. This Training Program takes a holistic approach to train graduate students and postdoctoral fellows in innovative and interdisciplinary approaches to study host-microbial interaction. We combine rigorous courses, mentored laboratory-based research, and an array of training activities all within a Program focused on the highest standards of ethics and research conduct